VISION RESEARCH CORE GRANT

SUMMARY – OVERALL
This application seeks five years of continued support for an NEI Core Grant that has facilitated the research
efforts of vision scientists at the University of California, Davis for the past 20 years. The goal is to enhance
vision science by providing cost-efficient, stable, and shared resources that are not generally available to
individual laboratories. It will enhance collaborations and translational research among a large group of 35
funded vision scientists at UC Davis who hold 20 Core-eligible NEI R01 grants. It will also facilitate collection of
preliminary data for new grant applications by funded and yet-to-be-funded UC Davis laboratories, and sharing
of resources developed for UC Davis with the vision science community outside of our institution. Building on
our strengths and new directions in the field, we have redesigned the currently funded cores to better serve the
needs of our NEI investigators. The proposed Cores are: (i) Software Engineering, (ii) Molecular Construct and
Packaging, (iii) Microscopy and Tissue Processing, (iv) Small Animal Ocular Imaging, and (v) Large Animal.
Each Core Director has one or more NEI R01 grants, and is supported by talented and skilled technical staff.
These five Cores provide custom facilities and personnel that serve the needs of our NEI investigators and their
trainees. The administrative structure includes an Executive Committee, comprising the Principal Investigator
and the Core Directors, along with regular input from all vision scientists on campus, and a distinguished group
of External Advisors. Priorities for use of core facilities have been carefully honed and made available to all
investigators. The administration of UC Davis has been and continues to be exceptionally supportive of vision
research on campus. This is demonstrated by a substantial increase in the number of vision scientists recruited
to the university, with a commensurate increase in NEI-funded grants. This growth is further buttressed by
institutional support in the form of seed grants to stimulate new research in vision science, the planned
recruitment of new faculty in vision science, and funding for the Center for Vision Science, which provides a
means for unifying our community of vision researchers and fostering collaborations with an accomplished cohort
of biologists on campus and vision scientists at other institutions.

Public health relevance
PROJECT NARRATIVE – OVERALL This Core grant provides shared facilities for an energetic and productive cohort of scientists at the University of California Davis who seek to understand structure and function of the visual system in health and disease. It provides an environment that facilitates collaboration across vision science disciplines and clinical vision science.